FOOD AND GASTRIC PH ON ORAL BIOAVAILABILITY OF ITRACONAZOLE IN HIV PATIENTS

The purpose of this study is to determine whether the oral bioavailability of itraconazole in HIV-infected subjects can be increased by administration with glutamic acid and/or food.